Infection prevention strategies after CAR-T cell therapy

PROJECT SUMMARY/ABSTRACT
Patient-oriented research of infection prevention strategies in chimeric antigen receptor T cell
therapy (CARTx) recipients will facilitate improvement in clinical outcomes and a wealth of
opportunities for trainees. This award will provide protected time for Dr. Hill to mentor trainees in
clinical research related to mitigating the immune-related adverse effects from CARTx, thereby
reducing infectious complications. This proposal will study the use of passive and active
immunotherapeutic strategies to prevent infections after CARTx, including immunoglobulin
replacement therapy (IGRT) and vaccination. In Aim 1, Dr. Hill will conduct the first randomized,
controlled, multicenter trial of IGRT in 150 adult CARTx recipients with serum total IgG ≤400
mg/dL at five cancer centers. These data will provide critical insights into the potential risks and
benefits of IGRT in this patient population. The key objectives of this study are to evaluate whether
IGRT in CARTx recipients reduces infection rates compared to placebo, and to understand the
impact of IGRT on cytokine release syndrome, immune effector cell-associated neurotoxicity
syndrome, and healthcare resource utilization. As part of new research supported by this award,
patients will be administered a validated survey to evaluate whether IGRT is associated with
improvements in health-related quality of life (Aim 3), which will enable future cost-effectiveness
research. In Aim 2, Dr. Hill will conduct an open-label clinical trial using an inactivated rabies
vaccine in 28 CARTx recipients with relapse-free survival for ≥6 months, in addition to 10 healthy
controls. Vaccination after CARTx cell therapy may provide a more durable and cost-effective
approach to infection prevention than IGRT, but there are limited data to guide vaccination
strategies after CARTx. The objectives of this study are to determine antibody responses, and
clinical correlates of vaccine responsiveness, using a rabies virus vaccine as a neoantigen
challenge. The rabies vaccine provides a unique tool to assess immune responses while patients
are receiving prophylactic immunoglobulin given no or low anti-rabies immunoglobulin in these
products. Dr. Hill will build on this infrastructure to study innovative vaccination strategies to
improve immunogenicity in immunocompromised patients in Aim 4. He will conduct a pilot study
in 20 CARTx recipients using a ‘fractional escalating dose’ delivery for the initial vaccine dose,
followed by a booster ‘bolus’ dose. The objectives of this study are to determine whether the
fractional escalating dose strategy improves the proportion of patients who develop protective
antibody responses, which could shift the paradigm for vaccinating immunocompromised
individuals. These aims address critical knowledge gaps in CARTx recipients, provide a robust
infrastructure for POR training of physician scientists, and will provide the groundwork for future
studies to refine infection prevention strategies in the growing population of CARTx recipients.

Public health relevance
PROJECT NARRATIVE This award will provide protected time for Dr. Hill to mentor trainees in patient-oriented research in preventing infections in patients receiving chimeric antigen receptor T (CAR-T) cell therapy. The proposed studies will evaluate best approaches for the use of antibody infusions and vaccination to reduce infections after CAR-T cell therapy and improve patient outcomes.